2025 Consciousness, Anesthesia and Evolutionary Biology Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
This proposal requests partial support for a conference on Consciousness, Anesthesia and Evolutionary Biology
as part of a Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) to be held from January
26-31, 2025. The broad, long-term goal of this conference is to bring together neuroscientists,
anesthesiologists, neurologists, psychiatrists, and evolutionary biologists to discuss cutting-edge research
related to consciousness, cognition, and mental health. The 2025 conference will include a GRS for graduate
students, postdoctoral fellows, and early career investigators, to be held immediately prior to and in conjunction
with the GRC. The specific aims of this meeting will be to convene 30 leading experts who will present rigorous,
impactful science at scales of study that span from molecular and circuit neuroscience to animal and human
imaging and behavior. This conference focuses on cutting-edge and unpublished research, prioritizing time for
discussion after each talk, and fostering informal interactions among scientists of all career stages. Afternoon
poster sessions will permit all participants to contribute to these topics, and participation by trainees will be
strongly encouraged. In addition, the GRS will be specifically aimed at graduate students, postdoctoral fellows,
and early career investigators, allowing them to present their research in a relaxed and supportive environment.
Every effort will be made to promote diversity and gender parity. The significance of this application lies in a
much-needed forum provided by the GRC and GRS to bring together and synergize members of the international
research community working on consciousness. The GRS will help to train and inspire the next generation of
investigators who will move the field forward. The health relatedness of this application is that our conference
will address key topics relevant to human health, including mechanisms of consciousness, unconsciousness,
and altered consciousness; novel approaches to prognosticate and treat disorders of consciousness; the
potential for anesthetic- and psychedelic-induced states to treat neuropsychiatric disorders; and how to improve
cognitive recovery in patients undergoing general anesthesia. We will also explore the evolution of
consciousness, sleep, and hibernation across diverse species, which will stimulate multidisciplinary discussions
and lead to new insights and approaches to improve brain health in humans.

Public health relevance
PROJECT NARRATIVE Understanding the neuroscientific underpinnings of consciousness has broad implications for human health, including the treatment of disorders of consciousness due to brain injury, sleep disorders, perioperative neurocognitive disorders, and neuropsychiatric disorders. These topics are studied by investigators in diverse fields including neurology, anesthesiology, psychiatry, sleep medicine, and evolutionary biology, who may not be familiar with each other’s work. This Gordon Research Conference (GRC) and Gordon Research Seminar (GRS) will bring together these experts from around the world to discuss recent findings that will advance the development of novel strategies to treat these complex clinical problems.